NON-INVASIVE IMAGING METHODS FOR RECEPTOR BINDING IN NON-HUMAN PRIMATE MODELS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The primary goal of this project is to develop and test non-invasive imaging methods, including dopamine receptor ligands, for non-human primates. The secondary goal of this project is to test behavioral correlations (ex. sucrose consumption) with these receptor measures.